MODULATION BY CYTOKINES OF RESISTANCE TO HISTOPLASMOSIS

The zoopathogenic fungus Histoplasma cap is a facultative intracellular parasite of the mononuclear phagocytes of a host. Accordingly, recovery from an infection and the consequent acquired resistance to reinfection are, predominantly intracellular events governed by cytokines. The thesis of this proposal is that the outcome of experimental histoplasmosis is predominantly an intracellular event controlled by cytokines, and that progressive histoplasmosis results from a failure in proper regulation of cytokines. The specific aims of this proposal which are designed to test the hypothesis are: First to study the modulation of TNF-alpha and IFN-gamma in an infected host. By depleting these two cytokines in animals at different times after infection, one can study the influence of them on the course of infection. Second, to study the activation of TH1 and TH2 CD4+ T cell subsets in the immune response to histoplasmosis by resistant A/J and susceptible C57BL/6 strains of mice and to relate their presence to recovery from or persistence of an infection. Levels of IFN-gamma, IL-2 and IL-4 in the spleens and lymph nodes of infected mice will be measured to assess the dominance of one or the other TH subset. The difference of macrophage antigen presention in the two strains of mice will be assessed to determine whether that influences the preferential activation of one or the other TH subset. Third, to identify the locus of resistance or susceptibility to histoplasmosis in animals by studying the response to experimental infection of recombinant inbred progeny of C57BL/6 and A/J mouse strains. The responses to be measured will be survival, fungous numbers in tissues and lymphokine production including IFN-gamma, TNF-alpha, IL-2 and IL-4. The study will lead to a better understanding on the immunological basis for resistance to histoplasmosis.